Monitoring methamphetamine abuse treatment with 1H MRS

To find out whether people who were dependent on methamphetamine have abnormal brain chemistry or abnormal thinking and memory, and to determine whether behavioral treatment for methamphetamine-dependence is associated with improvement of brain chemicals and thinking processes. To determine whether MRS can be used as a tool to predict the length of time to relapse.